COBRE: U KS: CORE C: PROTEIN STRUCTURE LABORATORY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. COBRE Core C is also known as the Protein Structure Laboratory (PSL). It is housed in the Structural Biology Center on the West Campus of The University of Kansas. The mission of the Protein Structure Laboratory (PSL) is to assist researchers in obtaining three-dimensional structures of their protein(s) of interest by X-ray crystallography. This is accomplished by maintaining the infrastructure and providing the expertise necessary to conduct crystallographic experiments. To facilitate this, modern crystallization methods, in-house or synchrotron X-ray diffraction data collection, and the most recent crystallographic software are utilized. The staff consists of one experienced full time Ph.D. crystallographer who serves as the Director of the Laboratory, a Core Advisor, and a Research Assistant to conduct equipment maintenance.